Circadian Disturbance and Dementia in Latin America

Project Summary/Abstract
The prevalence of dementia continues to rise as the elderly population is growing across the world, especially in
the Latin America population. Identifying modifiable factors that can be the targets for preventing or delaying
dementia and its adverse impacts on life quality is of great relevance to public health. Almost all
biological/physiological processes such as sleep and physical activity levels are modulated by the circadian
system and display orchestrated circadian rhythms in sync with the day-night and sleep-wake cycles. There is
an established foundation as well as overwhelming epidemiological evidence for adverse health consequences
of disrupted circadian rhythms such as sleep disorders, cardiometabolic disease and cognitive impairment.
However, previous circadian studies were mainly performed in high-income countries such as the US and
Europe, and circadian health and its link to dementia in Latin America are unknown. The goal of this project is to
determine the involvement of circadian disturbance in the characterization of Alzheimer’s disease (AD) and
frontotemporal lobar degeneration (FTLD) in Latinos. To achieve this goal, PIs and their team will utilize the
existing the database of ReDLat (Multi-Partner Consortium to Expand Dementia Research in Latin America), in
which over 3,000 Latinos in three groups of participants (AD, FTLD, and controls) aged between 40 and 80 years
old have been enrolled and underwent or will undergo a multidimensional assessment including social
determinants of health (SDH), socioeconomic status (SES), neurocognition, multimodal neuroimaging, and
whole-genome sequencing. In this project, the ambulatory motor activity recordings (actigraphy) will be collected
from a subset of ReDLat participants and used to quantify daily activity rhythmicity and fractal motor activity
patterns that provide complementary assessment of the multiscale regulatory function of the circadian system.
Using these circadian measures together with clinical assessment, diagnosis, cognition, genetics, three aims will
be addressed: (Aim 1) Determine the effects of age, sex and SDH/SES on circadian disturbance in Latinos; (Aim
2) establish the links between circadian disturbance, dementia, and cognitive function in Latinos; and
(Exploratory Aim 3) Explore the genetic contribution to the link between circadian disturbance and
cognition/dementia in Latinos. Achieving the aims will potentially establish a novel framework to identify the
circadian disturbance features in AD and FTLD in Latin America, and will offer a large, curated, multimodal
dataset for future research. The results to be obtained not only are scientifically important but also may reveal a
potential target (i.e., circadian health) for prevention and/or treatment of dementia and related adverse
complications.

Public health relevance
NARRATIVE Almost all biological/physiological processes such as sleep and physical activity levels display circadian rhythms (of ~24 h) that are regulated by the endogenous circadian system, and disrupted circadian rhythms are linked to many adverse health outcomes including increased risk for sleep disorders, cardiometabolic diseases, and dementia. Using the existing cohort of ReDLat (Multi-Partner Consortium to Expand Dementia Research in Latin America) and an unobtrusive assessment of circadian health, this project is proposed to examine the effects of age, sex, and socioeconomic factors on circadian function in Latinos, and the involvement of circadian disturbance in the characterization of two types of dementias (Alzheimer’s disease and frontotemporal lobar degeneration) in this underrepresented population. The project will help address Latino health disparities, provide a sustainable, scalable and equitable approach to circadian health monitoring and a non-invasive tool for assessment or identification of dementia, and lead insights into the relevance of circadian disturbance to the high and increasing prevalence of dementia in Latin American countries.